Investigation of the role of X-Linked Inhibitor of Apoptosis Protein in African American IBC-derived

Statement of Work Risa is a PhD student in both the University Program in Environmental Health and Toxicology in the Nicholas School of the Environment and the Department of Pathology in the Duke University School of Medicine. She is a member of the Devi lab in the Duke Department of Surgery, Division of Surgical Sciences, and will be mentored additionally by Dr. Kevin Williams of NCCU and Dr. Steven Patierno of DCI. Risa is concurrently receiving training in disparity and equity principles as a selected member of the 2016 cohort of BioCoRE, an office of biomedical graduate diversity program at Duke. She is also a selected PhD fellow in the Duke/NCCU Cancer Research Education Program (2018-2020), funded by the parent P20 grant. She is further an active member of the Duke chapter of the Society for Advancing Chicanos and Native Americans in Science (SACNAS). She is committed to scientific research and training, and a contributing member of the diverse minority scientist community at Duke. Risa will conduct research in concordance of the P20 parent grant aims. Aim 1. To investigate whether XIAP drives organoid formation and growth in AA IBC tumor organoid models. Aim 2. To establish that XIAP modulates anti-cancer drug efficacy in AA IBC tumor organoid models.

Public health relevance
Project Narrative One in eight women will develop invasive breast cancer in their lifetime, and aggressive, treatment resistant breast cancers have poor survival outcomes. Inflammatory Breast Cancer (IBC) is one of the most aggressive breast cancer subtypes and the most lethal, and disproportionately affects African American (AA) women who exhibit higher rates of rapid tumor growth, treatment resistance, and poor survival. A growing body of evidence suggests that the potent anti-apoptotic X-linked Inhibitor of Apoptosis Protein (XIAP) is linked to breast tumor progression and therapeutic resistance. The proposed project will investigate the mechanistic role of XIAP in tumor growth and treatment resistance in AA women using highly innovative 3D IBC tumor organoid models, high content imaging, and high throughput drug screening techniques. The proposed work will address the urgent need to interrogate the molecular mechanisms driving the more aggressive IBC biology and treatment resistance in AA women, thereby identifying the link of this aggressive tumor phenotype to modifiable IBC risk factors, and targets that can be modulated for therapeutic benefits.